Targeting a Novel Secreted Immune Checkpoint to Enhance Liver Cancer Immunotherapy

PROJECT SUMMARY/ABSTRACT
Liver cancer, particularly hepatocellular carcinoma (HCC), is a leading cause of cancer-related deaths globally
and one of the fastest-growing cancers in the United States. Despite the approval of immune checkpoint
inhibitors (ICIs) for advanced HCC, most patients experience unsatisfactory therapeutic outcomes due to the
immunosuppressive tumor immune microenvironment (TiME) in HCC, which limits effective T cell responses.
Our long-term goal is to understand the mechanisms underlying cytotoxic T cell suppression and resistance to
ICIs, and to identify potential drug candidates for combination therapy with ICIs or innovative strategies to
improve the outcomes of adoptive T-cell therapy. The objective of this proposal is to investigate how the LIFR-
LCN2 pathway in liver cancer restricts the cytotoxic function of CD8+ T cells to lead to immune evasion and
resistance to immunotherapy. The proposed work is strongly supported by our preliminary studies: 1) Acquired
resistance to PD-1 blockade correlates with decreased Lifr and increased Lcn2 levels; 2) LIFR overexpression
suppresses HCC in a CD8+ T cell-dependent manner; and 3) the LIFR-LCN2 pathway inhibits the activity of CD8+
T cells. Our central hypothesis is that loss of LIFR upregulates LCN2 in liver cancer, thereby suppressing the
abundance and cytotoxic function of CD8+ tumor-infiltrating lymphocytes (TILs) through MC4R, leading to
immune evasion and resistance to immunotherapy. Our rationale is that uncovering the mechanisms behind the
suppressed cytotoxic function of CD8+ TILs in the hostile TiME of liver cancer will open up new therapeutic
opportunities for liver cancer patients. The central hypothesis will be tested by pursuing two specific aims: (Aim
1) Investigate whether the LIFR-LCN2 pathway inhibits the effector function of CD8+ T cells; (Aim 2) Determine
strategies to target LCN2-MC4R signaling to enhance immunotherapy. This study is significant due to its potential
to reveal novel mechanisms of immune suppression in liver cancer and identify new therapeutic targets. Our
findings suggest that LCN2 functions as a ‘‘secreted immune checkpoint’’ that hampers anti-tumor immunity,
indicating that inhibiting LCN2-MC4R signaling could be a valuable strategy to enhance liver cancer
immunotherapy. The proposed research is innovative in its exploration of a novel immune regulatory pathway in
HCC, its potential to enhance the efficacy of ICIs and CAR-T cell therapy through combined therapeutic
strategies, and its integration of mechanistic insights with translational research approaches.

Public health relevance
PROJECT NARRATIVE This project will investigate the impact of LIFR-LCN2-MC4R pathway on CD8+ T cell function in liver cancer, focusing on how this axis contributes to immune evasion and resistance to immunotherapy. By leveraging genetic and immunological models, we aim to identify novel therapeutic targets to enhance the efficacy of immune checkpoint inhibitors (ICIs) and CAR-T cell therapy in hepatocellular carcinoma (HCC). The results will offer critical insights into overcoming current treatment limitations and advancing innovative strategies for improving liver cancer outcomes.